Measurement and Mechanisms of Pain in Autistic Adults

Project Summary/Abstract
A growing literature suggests autistic adults feel pain in a different manner than non-autistic adults and may
experience more persistent pain than the general population. As pain is often the first sign of injury or illness,
individual differences in pain perception or communication can significantly impact diagnosis and treatment of
many health conditions. Alternatively, when pain is not addressed, this can lead to a pro-nociceptive pain profile,
where endogenous systems facilitate pain instead of inhibiting it, potentially contributing to persistent pain.
Autistic adults often experience sensitivity in other sensory domains that could extend to pain. For example,
hyper-responsiveness can include pain-like reactions to everyday tactile stimuli like tags on clothing. At this point,
several studies have demonstrated increased pain sensitivity2,3, increased pain-related anxiety2, and altered
neural responses to pain1 in autistic individuals. Yet, several important questions remain that present barriers to
improving pain treatment in autistic individuals. In this project, we propose to address several gaps in our current
understanding, building a framework to investigate pain sensitivity in autism. First, we will address pain
assessment and expression of pain in autistic adults. Currently, there is no consensus recommendation on pain
assessment in autism. It is not clear if autistic individuals express pain in specific ways that differ from non-
autistic individuals and if better pain assessment tools would improve pain management. In Aim 1, we propose
to test different pain scales in self-reporting autistic adults to determine reliability. Additionally, we will assess
how pain ratings on these scales correspond to observable pain behaviors. Secondly, we will address potential
factors that may predict persistent pain in autism. It is currently unknown if hypersensitivity to pain extends from
a general sensory hypersensitivity for autistic adults. In Aim 2, we will explore individual profiles of sensory
reactivity to identify important relationships between pain and sensitivity in other sensory domains. We will also
explore relationships with social and emotional factors that may impact persistent pain. Lastly, in Aim 3, we will
address potential brain mechanisms of pain sensitivity in autistic adults. Our previous work indicated that autistic
adults have a different neural response to heat pain across somatosensory and affective brain regions, but the
functional connectivity of these regions and the relationship between neural responses and pain reports is not
clear. Overall, we hypothesize that autistic adults have difficulty communicating their pain, leaving them at a
greater risk for mismanagement of pain. Additionally, we hypothesize that autistic adults likely have a pro-
nociceptive profile increasing the magnitude of pain. This combination of difficult pain communication and a pro-
nociceptive profile leaves autistic individuals at risk for persistent pain and is a detriment to their overall health.
At the conclusion of this project, our work could inform how clinicians assess pain in autism (Aim 1), identify
autistic individuals at most risk for persistent pain (Aim 2) and spark new mechanisms to improve pain
management in autistic adults (Aim 3).

Public health relevance
Project Narrative Autistic people may experience more persistent pain but may have more difficulty communicating their pain. In this project, we aim to identify better pain measurement for autistic adults and to understand factors that may result in more pain for autistic people. We will also examine how the brain may respond differently to pain in autistic adults with the aim of identifying new targets of pain treatment for autistic individuals.